Core B: Biostatistics & Bioinformatics

Core B Abstract
The mission of the Biostatistics & Bioinformatics Core (Core B) is to support the SPORE, Career Enhancement
Program, and the Development Research Program projects through a variety of services, support, methods
development and computational infrastructure. Core B is led by faculty geneticists, statisticians,
biostatisticians and is staffed by senior LCCC Bioinformatics and Biostatistics shared resource members who
will directly participate in all projects and be integral partners with each project. This centralized core will
provide scientific leadership and resources for statistical and bioinformatics analysis of complex data sets, and
utilizes existing shared resources supported by the Lineberger Comprehensive Cancer Center including strong
support for informatics, high performance computing clusters, and biostatistics support. This Core and its
personnel have a track record of translational and computational accomplishments that will be applied to new
cutting-edge technologies including single cell sequencing and spatial genomics approaches. Complementary
skills possessed by the Core faculty will also lead to the application and development of (as needed) cutting-
edge approaches for to cross-platform data integration and high-dimensional biomarker discovery to facilitate
patient subtyping and optimize clinical decision-making. The Biostatistics & Bioinformatics Core (Core B) will
provide support for each of the SPORE projects as well as the Career Enhancement Program (CEP) and the
Development Research Program (DRP).